Interrogation of the oxidative-stress-induced leukemia program in vivo usingmetabolic imaging

PROJECT SUMMARY/ABSTRACT (unchanged from initial application)
Acute myeloid leukemia (AML) is a genetically complex and heterogeneous set of diseases characterized by a
diverse set of mutations. Although many patients initially respond to treatment, many end up relapsing. Over the
last decade, an appreciation of the genetic diversity and clonal hierarchy in AML has opened the door to novel
therapeutic targets and therapeutic approaches to specific AML subtypes. Moreover, AML has been found to
bear unique metabolic features with therapeutic implications. Most importantly, mutations in the enzymes
isocitrate dehydrogenase (IDH1/2) have led to clinically approved drugs. However, many patients become
resistant to this therapy as well, further underscoring the need for new strategies to target dysregulated
metabolism in leukemia. Through the development of novel microcoil platforms to explore leukemia metabolism
with HP MR (Jeong et al. Science Advances 2017) we have identified a new metabolic vulnerability in the
glycolytic metabolism of leukemia (Jeong et al. Cell Metabolism 2021). This reliance on glycolytic metabolism
alters not only glucose flux to lactate, but also one-carbon flux through the serine pathway, which facilitates the
metabolism of glutamine. Moreover, we found that genetically targeting or pharmacologically inhibiting the
enzyme that mediates flux through this pathway (PHGDH) capitalizes on a new vulnerability in these cells.
Importantly, this targeting does not affect normal hematopoietic cell growth. Thus, building upon extensive
collaboration between our labs and ample preliminary data, we aim to employ innovative approaches to study
metabolism (Keshari Lab), including by developing non-invasive probes to measure changes in glycolysis and
oxidative stress with hyperpolarized magnetic resonance imaging. This metabolism will be characterized in well-
defined models of AML (Kharas Lab), with both genetic and pharmacological modulation, in order to develop a
strategy to assess leukemia-stem-cell-driven AML metabolism and the inhibition of serine metabolism.
Altogether, these studies will result in new mechanistic insights and novel cancer therapies.

Public health relevance
PROJECT NARRATIVE (unchanged from initial application) Leukemia remains difficult to treat, indicating an urgent need to develop new therapeutic strategies; thus, the overarching goal of the proposed research is to explore leukemia metabolism and develop novel biomarkers and therapeutic strategies. Our preliminary data demonstrates that specific metabolic pathways driving serine biosynthesis are increased in leukemia; these reflect vulnerabilities that we can develop imaging biomarkers to target. Our proposed work will facilitate future patient-specific treatment planning and novel experimental strategies for cancer treatment.